Neurotoxicity of Spermine Synthase-deficiency and Polyamine Imbalance

Title: Neurotoxicity of Spermine Synthase-Deficiency and Polyamine Imbalance
PI: R. Grace Zhai, PhD, University of Miami School of Medicine, Miami, FL
Co-I: Rich Steet, PhD, Greenwood Genetic Center, Greenwood, SC
Co-I: Luigi Boccuto, MD, Clemson University School of Nursing, Clemson, SC
PROJECT SUMMARY
Polyamines, namely spermidine, spermine, and their precursor putrescine are tightly regulated
polycations essential for life. First indications linking polyamine metabolism and neurological disorders came
from the observations of abnormal polyamine levels accompanying several brain injury conditions including
ischemic brain damage and traumatic brain injury. The pivotal role of polyamine metabolism emerged with the
mapping of causal mutation of Snyder-Robinson Intellectual Disability Syndrome (SRS, OMIM 309583) to
spermine synthase (SMS), an enzyme that catalyzes the conversion of spermidine to spermine. Our work in the
previous grant cycle (R01 NS109640) investigated the pathological consequence of polyamine imbalance in the
nervous system in the context of SRS. We have established a Drosophila model for SRS to recapitulate several
key features of SRS pathology, have uncovered altered redox state, dysregulated protein acetylation, and
lysosomal dysfunction as primary neurotoxicity underlying SRS pathology, and most importantly, have identified
phenylbutyrate (PBA) as a robust pharmacological suppressor of neurotoxicity in SRS in vivo models and in
patient cells. Recently, we made the exciting discovery of the critical connection between polyamine metabolism
and Tau aggregation-induced neurodegeneration. Specifically, we found that while complete loss of SMS causes
SRS, partial loss of SMS (SMS+/-, carriers) showed resistance to Tau-induced neurodegeneration in Tauopathy
models. This finding has two important implications: first, polyamines may regulate Tau aggregational toxicity;
and second, progression of neurodegeneration in Tauopathy could be delayed by modulating polyamine
metabolism. Our objectives for this renewal application are to establish the mechanistic link between polyamine
metabolism and Tau/amyloid aggregational neurotoxicity, and identify neuroprotective strategies based on
modulating polyamine metabolism using complementary model systems; 1) in vivo Drosophila models, 2) human
fibroblasts cells from SRS patients (male, SMS-/y) and heterozygous carriers (female, SMS+/-), and 3) gene
expression analyses of human Alzheimer’s Disease related dementia (ADRD) datasets. We hypothesize that
modulating polyamine metabolism and shifting spermine/spermidine ratio enhances autophagic flux, regulates
global acetylation landscape, facilitates the clearance of toxic Tau/amyloid oligomer species, and confers
resistance to neurodegeneration in proteinopathy. We propose to define metabolic and cellular mechanisms
underlying SMS+/- mediated neuroprotection against Tau/amyloid accumulation-induced neurodegeneration in
vivo in Drosophila (Aim 1); characterize autophagic flux and proteostasis in human primary cells of SRS patient
(male, SMS-/y), carriers (female, SMS-/+), and controls (+/+) (Aim 2); and carry out analysis of ADRD RNAseq
and protein expression datasets to identify polyamine dysregulation risk factors and metabolic targets for
neuroprotection against ADRD (Aim 3). The proposed research will reveal novel chemical and molecular
connection between polyamine metabolism and global protein homeostasis, and more importantly reveal a
previously unexplored therapeutic direction for AD pathogenesis.

Public health relevance
PROJECT NARRATIVE Dysregulation of polyamine metabolism causes a rare X-linked intellectual disability condition Snyder- Robinson syndrome (SRS), and impacts neurodegeneration in proteinopathy. The goal of this study is to define the neurotoxicity induced by polyamine metabolic dysregulation, delineate the neuronal mechanisms connecting abnormal Tau/amyloid-induced neurodegeneration and spermine synthase-deficiency, provide a new perspective on AD pathogenesis, and reveal a previously unexplored therapeutic direction for AD related dementia.